Purity Specifications, Storage and Distribution for Medications Development

This contract provides for the receipt, storage, shipment, and analysis of compounds and involves the maintenance of an extensive inventory and tracking system.